NONEMORY GCRC CORE LABORATOY ONLY PROTOCOLS

The GCRC Directors serve as PIs for Lab Only protocols. The Core Lab performed urinary analyses for total nitrogen, urea and creatinine for Dr. David Ludwig, Boston Children's Hospital, GCRC #97-12-231 entitled Dietary glycemic index and the neuroendocrine reponse to weight loss.